Prognostic and Therapeutic Roles of Voltage Gated Potassium Channels in Managing KIT Mutant Gastrointestinal Stromal Tumors (GIST)

PROJECT SUMMARY/ABSTRACT
Gastrointestinal stromal tumors (GIST) are most often driven by oncogenic KIT mutations and are treated with
FDA-approved tyrosine kinase inhibitors [TKIs, including imatinib (IM)] that target constitutively active KIT.
However, these drugs are only modestly effective. Even in the treatment naïve setting, ≤10% of patients have
complete responses to treatment. Thus, TKIs do not kill every tumor cell despite the absence of secondary
resistance mutations in KIT. Data from our lab demonstrates that treatment naïve KIT mutant GIST contain
subpopulations of IM-resistant “persister” tumor cells that lack KIT, but do express Kvβ1.1, the protein product
of the KCNAB1 gene. Kvβ1.1 regulates the channel activity of pore-forming α-subunits in voltage-gated
potassium channels (VGKCs) that allow cells to modulate plasma membrane potential and cell volume
homeostasis that, in turn, critically affects processes central to cancer biology (cell cycle regulation, cell migration
and invasion). FDA-approved in 2010 for treatment of multiple sclerosis, 4-AP (fampridine) blocks VGKCs to
improve motor skills. We now find that 4-AP synergizes with IM in vitro and in a murine model to better treat KIT
mutant GIST vs. IM alone. Our preliminary evidence strongly supports two Central Hypotheses: 1) high Kvβ1.1
protein (or high KCNAB1 mRNA) expression unequivocally identifies TKI-resistant persister cells in KIT mutant
GIST; and 2) combined with KIT targeting by IM, the VGKC complex is a novel therapeutic target for eradicating
both TKI-sensitive and TKI-resistant tumor cells in KIT mutant GIST. Our Overall Objectives are to: 1)
determine the safety and tolerability and to assess the radiologic and pathologic efficacy of IM with 4-AP in a
Phase 1 (3+3 design) neoadjuvant trial of 9-18 patients with treatment naïve KIT exon 11 mutant GIST (Aim 1);
2) validate pretreatment Kvβ1.1 protein or KCNAB1 mRNA expression as biomarkers predicting treatment
response (Aim 1); 3) determine how genetic and pharmacologic modulation of VGKCs impacts cancer-relevant
cell biology to define mechanisms mediating VGKC regulation of GIST aggressiveness (Aim 2); and 4) study
KIT mutant GIST tumor prognosis (Aim 3). At our high-volume “GIST Center of Excellence” at the NCI-
designated Moores Comprehensive Cancer Center at UC San Diego, we have united eight distinct
investigators and their teams towards achieving a common goal: to drastically improve outcomes in KIT
mutant GIST. This multi-disciplinary team includes expertise in: i) GIST surgical & medical oncology (Sicklick &
Fanta); ii) conduct of clinical trials (Sicklick, Fanta, Messer); iii) radiology & mRECIST measurements (Hahn);
iv) GIST pathology (Hosseini); v) GIST cellular & molecular biology (Sicklick); vi) computational biology & single
cell omics (Mesirov & Tamayo); vii) VGKC biology (Joiner); and viii) biostatistics (Messer). Our project will: 1)
test a new combination strategy for treating KIT mutant GIST; 2) have immediate applications for a follow-on
Phase 2 clinical trial to test efficacy in for treating GIST; and 3) validate novel ways to eliminate persister cells
that could be paradigm shifting, and ultimately lead to a cure for GIST.

Public health relevance
PROJECT NARRATIVE Gastrointestinal stromal tumors (GIST) are most often caused by mutations in the KIT proto-oncogene and are characterized by variable biology ranging from small, indolent tumors to large, aggressive tumors with a high risk of progression and metastasis. There is a pervasive belief in the GIST field that tyrosine kinase inhibitors (TKIs) that target KIT are a panacea to cure this cancer, but all FDA-approved anti-KIT drugs (including imatinib) have low to modest response rates at best, leading to the dispiriting conclusion that new drugs must be developed to target tumor cells in a KIT-independent fashion. This proposed revised R01 will: 1) study Kvβ1.1 [a regulatory subunit of voltage-gated potassium channels (VGKCs)] encoded by the KCNAB1 gene that our lab has discovered is a novel prognostic biomarker of imatinib-resistance in GIST; 2) evaluate the safety and tolerability of a new combinatorial treatment strategy combining imatinib with 4-AP (fampridine), an FDA-approved VGKC blocker; 3) test highly novel hypotheses to determine the mechanism(s) of action of this combination therapy; 4) develop new molecular tools to predict prognosis of KIT mutant GIST; 5) immediately improve patient outcomes and well-being; and 6) thus, offer new hope to those suffering from this rare, but potentially deadly form of cancer.